Network of the National Library of Medicine Region 1 Administrative Core

Region 1 Administrative Core Summary/Abstract
The University of Maryland, Baltimore (UMB) RML Team leads a responsive outreach and
engagement program that addresses the emerging needs of a large and diverse region.
Built on experienced leadership, highly-skilled coordinators and seasoned support staff for fiscal
responsibility, the RML is supported by a governing body of four advisory groups. The make-up
of Region 1 NNLM members who serve on the Senate, Library Advisory Board, Community of
Interest Leaders, and Executive Committee reflects the full diversity of regional membership and
guides the RML direction to:
• Shape the program and ensure that it is relevant, community-driven, and impactful.
• Support the mission of the NNLM and contribute to national goals.
• Help the RML meet network performance measures.
• Integrate diversity, equity and inclusion in all aspects of the RML program.
This member-centric governance structure supports the RML in cultivating an inclusive, diverse,
and thriving network membership, cultivated with cultural humility and supported to work for
social justice and health equity toward community resilience.
The RML Team collaborates multi-regionally with other RMLs, and NNLM Offices and Centers
to implement effective network membership recruitment strategies, maintain a continuation of
operations plan that guarantees national and local service, and conduct program evaluation to
guide, monitor, and continually improve RML and national programs.